Administrative Core

The Administrative Core is the umbrella organization for the Program Project. The purpose of this core is to provide programmatic direction and promote interaction between the investigators through regular internal meetings and through an annual meeting with a scientific advisory committee that will be selected. It will coordinate communications with the National Institutes of Health, and will provide help with budget management. The Administrative Core is led by the Program Director, Dr. Mitchell Kronenberg. Co-Director Dr. Yun-Cai Liu will assume the role of Director in Dr. Kronenberg's absence. Research Administrative Assistant (RAA) Ms. Jennifer Lagos will coordinate meetings and communications with the four principal investigators and their assistants, with members of their research groups, with Institutional review boards and with the Scientific Advisory Committee.

Public health relevance
The Administrative Core of the Program Project will facilitate interactions between the projects and with the National Institutes of Health.